DIGITAL BLOOD FLOW AND VASCULAR TONE

Our objective is to detect and quantitate differences in the pathophysiologic determinants of digital blood flow amongst normal subjects, patients with idiopathic Raynaud's Disease, and patients with Raynaud's phenomenon secondary to scleroderma. It is our aim to understand the abnormalities leading to digital artery spasm. Previous work suggests that Raynaud's phenomenon results from an abnormal vasoconstrictor response of digital arteries due to 1) abnormal vascular reactivity; or 2) abnormal neural and humoral stimuli acting on otherwise normal vessels. To this end, vascular reactivity will be studied by determining digital arteriolar opening pressure and segmental arterial systolic pressures to gauge arteriolar and arterial vascular tone as well as the sites of action of drugs and vasomotor responses; capillary blood flow and arteriovenous shunt flow will be measured to determine vascular resistance. Vasoconstrictor responses to (1) the sympathetic nervous system (environmental cooling, mental stress and intra-arterial tyramine); (2) the intra-arterial infusion of norepinephrine and epinephrine (circulating catecholamines); and (3) local digital cooling will be compared in normal subjects and patients. The ability of vasodilators to reverse these vasoconstrictor responses will be studied (isoproterenol, nitroprusside, nitroglycerin, phentolamine, prazosin, histamine, dopamine, nifedipine and acetylcholine). A direct indication of sympathetic nerve activity will be compared in normal subjects and patients by determining the overflow of norepinephrine from sympathetic nerves in the hand during environmental and local cooling, mental stress and drug administration. To determine overflow, the arteriovenous difference of norepinephrine will be determined by high performance liquid chromatography; extraction of norepinephrine by the hand will be determined by a double radioisotopic tracer technique. Functional differences in prejunctional control of sympathetic nerve activity as it affects hand blood flow in normals and patients will be determined by studying effects of alpha- and beta- adrenergic, histaminergic, cholinergic and angiotensin II agonists and antagonists on the overflow of norepinephrine. Since chronic propranolol therapy is associated with peripheral vasospasm, the mechanism by which chronic administration of the drug increases digital and forearm vascular resistance will be studied.